Synthesis and Applications of functional Macromolecules

[unreadable] DESCRIPTION (provided by applicant): Nature relies on structured macromolecules in the form of proteins and catalytic RNA's that fold into specific three-dimensional structures and present reactive functionality in precise constellations in order to carry out the chemical processes of life. The structured nature of these molecules and what we have learned from proteins about structure/function relationships suggests that given the ability to construct macromolecules and control their three-dimensional structures, we could develop macromolecules with biomimetic capabilities and with entirely new chemical functions. Our goal is to develop a novel, basic technology for synthesizing macromolecules with designed three-dimensional shapes and capable of presenting multiple chemically reactive groups in controlled ways to perform new functions. Our approach is to synthesize small, rigid molecular building blocks (bis-amino acids) and couple them through pairs of amide bonds to create ladder oligomers. Each monomer contains multiple stereocenters that are set in the building block synthesis. The bis-amino acids are assembled on solid support, or in solution, in specific sequences to form constitutionally precise macromolecules with specific structures. We propose the following specific goals. 1) We will utilize our prototype monomer to synthesize several scaffolds with interesting structures and determine their structures. 2) We will measure the flexibility of linear and bow-shaped scaffolds. 3) We will develop syntheses of additional monomers. 4) We will synthesize macromolecules that display cavities with dimensions comparable to those of protein active sites and determine their structures. 5) We will discover peptides that selectively bind these cavitand scaffolds and characterize the interaction through structure determination and measurement of binding free energies. 6) We will develop syntheses for bis-amino acids that display an additional functional group akin to the side chain of an amino acid. 7) We will develop a general approach to the design of complex functional group arrays that are capable of biomimetic function and could be used for the development of nanoscale molecular devices. [unreadable] [unreadable]